Occupational Health and Injury Surveillance in Louisiana

PAR-20-312: State Occupational Safety and Health Surveillance
Louisiana Occupational Health and Injury Surveillance Program
Project Summary/Abstract
Over the past 16 years a strong occupational health surveillance program has been established in Louisiana
with the long-term objective of improving the health and well-being of Louisiana workers. Housed in the
Louisiana Department of Health, the Louisiana Occupational Health & Injury Surveillance Program
(Occupational Health Program) aims to strengthen and expand its occupational health surveillance capacity
through an Expanded Program consisting of three complementary surveillance programs that will share staff,
data sources, funding, and other resources. The Enhanced Fundamental Program will compile, analyze, and
interpret occupational health surveillance data from multiple data sources to identify trends and high-risk
occupations and industries; utilize health informatics to expand program capacity to perform occupational
health surveillance; identify, evaluate and respond to emerging and emergent occupational issues; and identify
and develop new data sources. The Fatality Assessment and Control Evaluation Program will develop,
implement, and maintain a multi-source system of work-related injury fatalities; perform select case-based
investigations to identify fatality risks; and develop recommendations to control or eliminate risks. The
Occupational Heat-Related Illness (HRI) Prevention Program will expand and maintain a multi-source
occupational HRI surveillance system of heat-related morbidity and mortality data; conduct case follow-back
investigations to capture exposure and work-related information; develop linkages between climate and health
data in partnership with climate agencies, and educate and train targeted audiences through a diverse and
established state-wide partner network. All three Occupational Health Program components will engage and
collaborate with a diverse range of local and state partners and stakeholders to develop procedures, policies,
recommendations and practices that protect workers; present findings in a variety of formats using various
communication channels; and implement an evaluation plan to determine the effectiveness and efficiency of
program activities and efforts.

Public health relevance
PAR-20-312: State Occupational Health and Safety Surveillance Louisiana Occupational Health and Injury Surveillance Program Project Narrative Work-related injuries and illnesses in Louisiana have significant economic and human consequences. The proposed occupational health surveillance programs aim to track the extent of work-related injuries, illnesses, and fatalities in Louisiana, and to develop and disseminate prevention strategies to reduce their impact.